Limbic Pallidum DBS for the treatment of severe alcohol use disorder

ABSTRACT
Alcohol use disorder (AUD) is a major cause of morbidity, with an economic burden estimated at ~$250
billion/year. Current pharmacologic and behavioral treatments of AUD have limited efficacy, and despite
increased knowledge of the neurobiology of AUD, the relapse rate has not improved over the past 50 years
(~55% within 6 months). Thus, identifying novel and more efficacious treatments to prevent relapse is an
urgent public health priority. This need is especially acute for patients with alcohol-associated liver disease
(ALD), for whom continued alcohol use is associated with high mortality and withholding of transplantation. In
this proposal, we aim to test a novel treatment approach for severe and refractory AUD: neuromodulation of
the reward circuit with Deep Brain Stimulation (DBS) of the limbic pallidum (LP). We hypothesize that LP DBS
prevents relapse to alcohol use by reducing craving and modulating behavioral and cognitive processes
associated with vulnerability to relapse like cue reactivity, reward processing, and impulsivity. We will test our
hypothesis by conducting an initial pilot study to test safety, tolerability, and feasibility of LP DBS in 3 patients
with severe AUD and concomitant advanced compensated (asymptomatic) ALD (UG3 phase). Upon meeting
the UG3 phase milestones, we will conduct a double-blind, randomized, sham-controlled trial to further test
safety, tolerability, and feasibility, and to assess preliminary efficacy of LP DBS for the treatment of severe
AUD (UH3 phase). For the UH3 phase, we will enroll 20 patients with severe AUD and concomitant advanced
compensated ALD. In both the UG3 and UH3 phases, we will assess alcohol use and craving pre- and post-
DBS at multiple time points. We will also assess target engagement and the effects of LP DBS on alcohol-
induced changes in the reward circuitry using PET scans and neurophysiology. This proposal could pave the
way for a new treatment approach (i.e., DBS) and a new target (i.e., LP) to treat patients with severe AUD and
other substance use disorders.

Public health relevance
NARRATIVE This proposal aims to test a new treatment for patients with severe and refractory alcohol use disorder using deep brain stimulation (DBS) of the limbic pallidum. If successful, this treatment will significantly improve the quality of life of this patient population. This treatment will also reduce the mortality rate and economic burden associated with alcohol use disorder.